ApoE, lipid and immune mechanisms of human neurons and glia

Abstract
There is a significant knowledge gap for how apolipoprotein E (APOE) function can modulate cellular responses
to lipid perturbations and inflammatory mechanisms in the neuron and glia dependent pathophysiology seen in
Lewy body dementia (LBD), Parkinson’s disease (PD), and Alzheimer’s disease (AD). This project will reveal
how APOE can mediate neuronal-glia interactions in their combined responses to lipid and inflammatory
processes.
Appropriate lipid transfer between neurons and glia via lipid transporters such as apolipoproteins, is essential for
maintaining metabolic and structural integrity of neurons, with dysfunction leading to synaptic and cellular
damage. APOE facilitates lipid transport between cells and is also involved in cellular responses to inflammation.
We hypothesize that APOE is a primary point of convergence for mediating neuronal and glial responses to lipid
accumulation and inflammation in the brain in aging and neurodegenerative diseases, and that alterations in
APOE function will modulate downstream pathophysiological mechanisms leading to degeneration. Using our
advanced and refined in vitro platform of human induced pluripotent stem cell (iPSC) derived neurons, astrocytes
and microglia, this proposal addresses new questions of how APOE modulates neuron-glia mechanisms induced
by elevated glycolipids, cholesterol and inflammatory processes, and how such mechanisms are key
determinants in the pathophysiology that leads to LBD, PD and late-onset AD.
To test this hypothesis, we have 2 Specific Aims:
Specific Aim 1 uses APOE3/3, APOE4/4, APOE2/2 and APOEKO human neurons, astrocytes, microglia and
neuron-glia co-cultures, under conditions of elevated glycolipids and cholesterol, achieved through
pharmacological inhibition of glucocerebrosidase and NPC1 pathways. APOE isoform specific function is also
examined using recombinant APOE isoforms. Experiments will measure adaptive and pathophysiological cellular
responses of lipid regulation and transport, structural damage to synapses and neurons, and readouts of cellular
function.
Specific Aim 2 uses the APOE iPSC neuron-glia platform to determine how APOE modulates neuron-glia
pathophysiological responses to inflammatory stimuli, and interactions of APOE with the classical complement
cascade. Experiments will determine APOE-dependent neuron, microglia and astrocyte responses to viral- and
bacterial-like inflammation induced by Poly(I:C) and LPS, on inflammatory pathway activation, APOE-
complement pathway interactions, lipid transport, pre-degenerative changes, and cellular dysfunction.
Clinical data shows that lipid dyshomeostasis and inflammation can significantly contribute to the etiology and
onset of age-related neurodegenerative disorders. The proposed experiments will provide critical neuronal and
glial mechanistic data on how APOE can regulate such lipid and inflammatory disturbances.

Public health relevance
Project Narrative Neuron-glia interactions are essential for physiological and pathological processes in the brain, and homeostatic shifts in neuron-glia crosstalk can lead to synaptic and neuronal degeneration in Parkinson’s disease (PD), Lewy body dementia (LBD) and Alzheimer’s disease (AD). Lipid elevations and inflammatory events are significant age-related and environmental risk factors for developing PD, LBD and AD, and we hypothesize that APOE is a primary point of convergence for mediating cellular responses to lipid accumulation and inflammation in the brain. Using an advanced in vitro platform of iPSC human neurons and glia gene-edited with different human APOE isoforms, this project systematically identifies the mechanisms by which APOE functionally interacts with lipid elevations and inflammatory stimuli to modulate downstream pathophysiological mechanisms; such critical analyses in human systems have not previously been performed.